HYDROXYUREA ALONE &IN COMBINATION W/ DDI VS DDI IN PATIENTS WITH HIV INFECTION

ACTG 307 - The purpose of this short term study is to determine the safety and tolerability of hydroxyurea (HU) at various dose alone and in combination with didanosine (ddI).